The impact of dyadic processes on smoking and cigarette craving: An experimental investigation of romantic partners and smoking friends

Smoking is the leading preventable cause of cancer and mortality in the US, with Covid hitting smokers
especially hard. Quitting is difficult (and smoking increased during Covid), yet interventions yield only mixed
success. Smokers often smoke and crave cigarettes in social settings. Public health research emphasizes social
factors in smoking, and clinical studies point to the need to better understand disrupted relationship dynamics
when a romantic partner or friend quits. Thus, it is striking that nearly all lab research (testing causal relations)
on smoking and craving tests smokers in isolation. This neglect of social factors extends to quitting practices.
Even on the most respected websites, the “social” advice for quitting offers fairly simplistic and incomplete tips
that fail to consider subtle yet powerful challenges that quitting may create for smoking friends and romantic
partners. Further, there is no evidence regarding how social factors exacerbate the altered smoking-related
decision-making that accompanies craving, thus raising the likelihood of smoking. To develop a comprehensive
understanding of the factors and processes that maintain smoking and increase relapse risk, basic
experimental research that integrates social processes into existing paradigms focusing on pharmacologic and
(individual) psychological aspects of addiction is needed. This basic experimental study with humans (BESH)
application addresses targeted NCI Behavioral Research Program priorities focused on leveraging research on
dyadic processes to examine health-related behaviors such as smoking cessation. Integrating theory and
research derived from three disciplines rarely applied to smoking (experimental social psychology with a focus
on dyadic processes, affective science, cognition), the project will offer a multimodal analysis of craving and
smoking in two social contexts relevant to smoking (friendships, romantic couples). This project will use
innovative measures of affect (e.g., an urge pressure dynamometer, speech volume, Facial Action Coding
System) and decision-making to test theoretically-derived processes (e.g., shared reality, motivated reasoning,
emotional contagion) that may help explain the challenges linked to quitting when rewarding social aspects of
smoking are lost. The project will elucidate why some smokers may struggle managing relationships when
quitting, and why social interventions may be most useful for a subset of smokers. In both a friends study and a
couples study, abstinent daily and nondaily smokers will be recruited. The friends study will test the impact of
a friend’s presence on cue-elicited craving, with a focus on shared craving states, and the couples study will
target effects of mutual smoking versus unilateral smoking on critical social interactions and relationship
perceptions thought to raise obstacles to quitting. This project will test important social-cognitive and socio-
emotional mechanisms underlying craving and smoking that may identify hidden social motives for smoking
that must be integrated into biopsychosocial smoking treatment. Regardless of outcome, this work will provide
valuable data on emotional and cognitive processes experienced in social settings during craving and smoking.

Public health relevance
Public Health Narrative Although quitting smoking is the most important action a smoker can take to prevent cancer, cessation has proven difficult. One’s social environment, including romantic partners and friends, play a major role in smoking, yet there is little experimental research examining smoking and cigarette craving in a social context. Integrating theory and methods derived from experimental social psychology, affective science and addiction research, disciplines rarely merged, this application seeks to identify key dyadic processes that help explain the challenges associated with quitting in order to develop more comprehensive models of smoking and smoking cessation that move beyond exclusively pharmacological approaches.